Task A70: ADENOVIRUS MOUSE MODEL FOR EVALUATION OF MEDICAL COUNTERMEASURES AGAINST MERS

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.